Harm Reduction Policing? A Qualitative Study of Police Culture and Enforcement Practices Toward People Who Use Drugs Amidst Efforts to Align Public Health and Public Safety Systems

Project Summary
The recent convergence of the overdose epidemic and continued racialized police violence has accelerated
efforts to mitigate the racially disparate harms of policing toward people who use drugs (PWUD) by aligning
law enforcement’s role as first responders with evidence-based public health approaches to drug use rooted in
harm reduction. Police departments now commonly equip officers with naloxone, participate in partnerships
with healthcare service providers, and have a lead role in celebrated diversion programs targeting PWUD and
other marginalized populations. Despite initial evaluations of these approaches showing promise in isolation,
widespread and enduring reform across the institution of policing has not materialized. Punitive enforcement of
drug offenses remains central to the institution of policing. True harmonization of criminal justice and public
health systems requires broad changes to well-established cultural and institutional norms. The proposed R36
application builds on pilot program evaluations and studies examining changes in isolated measures of police
enforcement by examining how police officers in Baltimore City, Maryland, negotiate, contest, and make sense
of drug policy reforms and guidance from public health authorities in order to understand how the broader
cultural shift toward evidence-based approaches to substance use is being translated into policing practices
that are ultimately experienced by PWUD. Through in-depth interviews with Baltimore Police Department
(BPD) leadership (n=20), observations of BPD public-facing events (n=15), and observational ride-alongs with
street-level officers (n=60), this research aims to qualitatively explore, 1) how police leadership integrate harm
reduction approaches to drug enforcement into the department’s organizational approach to PWUD, and 2)
street-level officers’ beliefs, attitudes, and enforcement practices towards PWUD. Analysis of interview
transcripts and observation fieldnotes will be conducted using an abductive approach, drawing on theories and
concepts from studies of organizations and organizational change, police culture, risk environments and
structural determinants of health. The PI of the proposed R36 application, Bradley Silberzahn, is a doctoral
candidate in the Department of Sociology at the University of Texas at Austin (UT Austin). Brad will lead all
study procedures, as well as a broader expert panel comprised of faculty from UT Austin, Johns Hopkins
Bloomberg School of Public Health, and New York University’s School of Global Public Health. This research
will inform ongoing debates over drug policy and the role of law enforcement in harm reduction, as well as
identify barriers and avenues for widespread and enduring police reform that facilitates police enforcement
practices that are in alignment with, not antithetical to, public health.

Public health relevance
Project Narrative The proposed R36 application seeks to examine how police officers in Baltimore City, Maryland, are responding to drug policy reforms and the broader cultural shift away from punitive responses to substance abuse that are associated with negative health outcomes for people who use drugs (PWUD) in favor of evidence-based public health approaches rooted in harm reduction. Through in-depth interviews with 20 senior officers of the Baltimore Police Department (BPD), observation of 15 public-facing BPD events, and 60 observations of street-level officers in the form of ride-alongs with patrol and detective units, this research will qualitatively explore the way BPD leadership integrate harm reduction approaches to drug enforcement into the department’s organizational approach toward PWUD, and street-level officers’ beliefs, attitudes, and enforcement practices towards PWUD. Findings will inform ongoing debates over drug policy and the role of law enforcement in harm reduction, as well as identify barriers and avenues for widespread and enduring police reform that facilitates police enforcement practices that are in alignment with, not antithetical to, public health.